Influence of Hippocampus-Like Memory Representations on Decision Making in Foraging Birds

Abstract
Mental disorders that impair the hippocampus significantly disrupt people’s capacity to form and
retrieve memories, which are essential for daily decision-making. My lab’s goal is to elucidate
the link between the biological properties of hippocampal neurons and their role in
memory-guided cognitive behaviors. This research will involve mapping these behaviors to their
underlying neural mechanisms through theoretical analyses and simulations of state-space
models, incorporating these models into a recurrent network architecture that reflects biological
plasticity rules. To capture memory-guided behaviors in their ecological complexity, my lab will
utilize cutting-edge behavioral tracking techniques to study the foraging behavior of wintering
birds with varying memory capacities: chickadees and sparrows.
My postdoctoral work in the Aronov lab (K99 phase), at Columbia University’s Zuckerman
Institute, focused on neural activity underlying a hippocampus-dependent one-shot memory
behavior, food-caching, in the model system chickadees, caching birds with extreme memory
abilities. I developed new methods for recording large populations of neurons in the chickadee
hippocampus while they cache and retrieve food, and methods for precisely tracking their
caching behavior. Probing the hippocampus at moments of caching, I found a new mode of
hippocampal activity patterns, which is reactivated when birds return to retrieve food. To
compare this one-shot mode to representations of consistent environmental features, I am
reproducing, in food-caching birds, findings from rodents showing changes to place cells at
consistent reward zones, and comparing this to one-shot representations of food-caching. I also
developed a theoretical state-space model that explains both one-shot and consistent
representations in the hippocampus, incorporating hippocampus-inspired neural mechanisms.
Here, I outline an R00-phase plan to study how variations in hippocampal capacity influence
decision-making processes during foraging, providing insights into the adaptive significance of
memory across species. In Aim 1, we will incorporate hippocampus-like representations into
decision-making models of optimal foraging behavior, including modeling agents with different
memory abilities, and test the hypothesis that that foragers simulated with varying hippocampal
memory capacities will exhibit distinct, systematic foraging strategies. In Aim 2, we will collect
3D tracking data of birds foraging in a natural environment, using an array of infrared thermal
cameras, and compare these trajectories to our model predictions. In Aim 3, we will extend
foraging models to include information transfer between different members of the flock,
modeling group foraging dynamics. By simulating information-sharing among agents and
comparing the outcomes with independent foragers, we will assess how social dynamics
influence foraging strategies. These models will be validated against the data collected in Aim 2
and existing observations of bird flocks, providing insights into the cognitive and social
mechanisms underlying natural foraging behavior.

Public health relevance
Project Narrative A core brain area responsible for memory is the hippocampus, which is impaired in a number of cognitive diseases, including Alzheimer’s. This work contributes to fundamental knowledge about the form of hippocampal representations, and their function in memory-guided cognitive behaviors.